The Vervet Research Colony as Biomedical Resource

PROJECT SUMMARY
This application is an administrative supplement to the "Vervet Research Colony as a Biomedical Resource"
(VRC, P40-OD010965). The purpose of this application is to obtain funds to support alterations and
renovations (A&R) to enhance the indoor animal housing space used by this unique nonhuman primate
resource. The VRC is the only NIH-funded biomedical research resource for US-born vervet/African green
monkeys (AGM; Chlorocebus aethiops sabaeus) and has been continuously funded since 2005. As an Animal
and Biological Material Resource (ABMR), the VRC serves a wide range of local, regional and national
investigators by providing animals, biological samples, data, consultation and training pertaining to the use of
vervets/AGMs as multi-categorical, translational models of human disease. The VRC has facilitated critical
translational research across a wide variety of disciplines, including: aging and Alzheimer's disease;
immunology and vaccine development; diabetes, metabolic disease and obesity; biomedical imaging; and
genetics, among others. The aims of the parent grant are to: 1) provide the scientific community with access to
animals, biological samples, data and expertise to facilitate the use of vervets for a wide-range of biomedical
research; 2) to provide exceptional training opportunities, and to serve as a platform for community and
scientific outreach; and 3) to enhance the resource by engaging in applied research focused on continuing
genetic and phenotypic characterization and expanding potential of the vervet as a translational model in novel
research areas. For this A&R supplement, we propose to design, build and install novel enrichment cages that
improve the physical and psychosocial environment for a subset of the animal population that can't be housed
in species typical social groups due to clinical or experimental reasons. We also propose to install infrared
cameras to add this new housing area to our existing 24h surveillance camera system; and to improve sensory
and cognitive enrichment. These efforts will enhance animal welfare and veterinary care, while also opening up
new research opportunities.

Public health relevance
PROJECT NARRATIVE The Vervet Research Colony (VRC) is a unique and valuable NIH-supported biomedical research resource dedicated to providing animals, biological samples, data, training and consultation on the use of vervets/African green monkeys for translational research. This alterations and renovations supplement will improve the existing facilities and add new functionality to this valuable nonhuman primate resource.